Investigating the Role of Nephronectin in Establishing Retinotectal Circuit Specificity

PROJECT ABSTRACT
An impressive feature of the nervous system is the specificity of its synaptic connections. Within the brain, a
single neuron is able to correctly identify and synapse onto its proper signaling partner over billions of other
neurons. How this degree of specificity is achieved is the subject of intense research. While great progress has
been made in identifying molecules that participate in long-range axon guidance and topographic positioning,
little is known in what molecules guide axons into their proper lamina once they reach their destined target region.
Through screening for extracellular matrix proteins differentially expressed by wide-field neurons in the
retinorecipient stratum griseum superficiale (SGS) of the superior colliculus (SC), I identified nephronectin (Npnt)
as a candidate for mediating synaptic specificity in retinotectal circuits. Npnt belongs to the EGF-like superfamily
of extracellular matrix glycoproteins and has been biochemically well-characterized to bind strongly and
specifically to integrin α8β1 (Itgα8β1).
My preliminary data show that 1) Npnt is exclusively expressed by wide-field neurons of the SC, whose cell
bodies define a lamina within the lower SGS; 2) Npnt deposits on the somata and proximal dendrites of wide-
field neurons, 3) loss of Npnt in the SGS results in ectopic αRGC axons within the upper SGS, and 4) alpha
retinal ganglion cells (αRGCs) express Itgα8β1
during development,
consistent with Itgα8β1 acting as the
receptor for Npnt on αRGCs. Taken altogether, I hypothesize that Npnt instructs αRGC axons to laminate within
the lower SGS through binding Itgα8β1 on αRGCs, thereby conferring synaptic specificity of αRGCs onto wide-
field neurons. This proposal will address how RGCs form precise connections to their neuronal partners within
the SC by studying how Npnt regulates axon laminar targeting and synapse formation. In Aim 1, I will determine
how Npnt mediates axon laminar targeting of αRGCs by focusing on its interactions with Itgα8β1. In Aim 2, I will
determine how Npnt affects αRGC synaptic partner choice within the SC. Completion of the proposed
experiments will reveal unique molecular and cellular mechanisms regarding the role of Npnt in specifying
neuronal pairing from αRGCs to wide-field neurons and will shed light on the function of Npnt in the mammalian
nervous system.

Public health relevance
PROJECT NARRATIVE The proper function of neuronal circuits critically depends on the ability of neurons to identify their correct synaptic partners. In this proposal, I identified the extracellular matrix glycoprotein nephronectin (Npnt) as a candidate for mediating synaptic specificity in retinotectal circuits and aim to understand its role in retinal ganglion cell subtype laminar targeting and synaptic choice. By uncovering new molecular cues that direct synaptic specificity within mammalian circuits, my study offers insights to inform therapies to regenerate these circuits in response to ocular and neurodegenerative diseases.